Implementation and Implications of Sickle Cell Trait Screening in the NCAA

ABSTRACT
In 2010 the National Collegiate Athletic Association (NCAA) adopted a mandatory sickle cell trait (SCT)
screening policy for student-athletes in its Division I (DI) colleges and universities. Currently, schools in all
three divisions of the NCAA are implementing the policy. To date, very little published research is available on
SCT in student-athletes or on the actual implementation of the NCAA screening policy. Many important
questions remain regarding this controversial mandated genetic screening program. Therefore, it is necessary
to better understand the policy's challenges, limitations, and risks, and to develop strategies to address them.
Our funded grant (R01HG010364-01A1) has two aims: 1) assess implementation, risks, and secondary
benefits of the NCAA SCT screening policy and determine contributors and implications of variation within
these domains using a mixed methods approach and 2) provide guidance on the current NCAA SCT policy and
practice and other similar public health policies and practices. Currently, we have completed data collection
and are working on data analysis to address Aim 1. To better interpret the results and develop strategies to
address the challenges in the policy, we will convene a national summit involving selected researchers,
practitioners, and decision-makers at institutional and policy levels. Summit participants will review the findings
from Aim 1, examine existing SCT management guidelines from the NCAA and NATA, collaboratively develop
recommendations for modifications to current procedures as needed, and identify and disseminate best
practices for future implementation of the NCAA SCT policy. Grounding of our research in the policy
implementation literature will also allow us to consider how our findings can inform other population-based
genetic screening efforts.
This supplement will facilitate the planning and execution of the national summit (Aim 2) and advance
the interpretation, application, translation, and dissemination of the results from Aim 1. Specifically, the
summit will provide a unique opportunity to share unprecedented information about the procedures,
perceptions, and outcomes of the NCAA policy with a diverse group of experts. It will also enable critical
examination of real and perceived benefits, risks, and effectiveness of the NCAA policy and other public health
genetics policies, and expedite efforts to address areas of concern. Overall, the project will establish a useful
empirical foundation for decision-making concerning future implementation of the NCAA policy and similar
policies and programs aimed at preventing illness and protecting the public's health.

Public health relevance
PROJECT NARRATIVE The sickle cell trait (SCT) screening program of the National Collegiate Athletic Association (NCAA) is regarded as one of the largest mandated genetic screening programs in the United States (US). Estimates suggest that over 2,000 NCAA Division I student-athletes with SCT will be identified under the screening policy and that, without intervention, about seven NCAA Division I student-athletes would die suddenly from a complication of SCT over a 10-year period. Our proposed project will facilitate the identification and resolution of issues that may impede the successful detection of SCT carriers and the application of effective interventions; it also aims to advance research and practice pertaining to the implementation of similar public health policies that target healthy subpopulations deemed to be at disproportionate risk.